Tau-dependent cognitive deficits in alpha-synucleinopathies

Summary/Abstract:
Parkinson’s disease (PD) is the second most common late-onset neurodegenerative disease
with the largest relative increase in mortality rates among all neurological disorders. PD is
traditionally considered a motor disorder, characterized by the loss of dopaminergic neurons of
the SNpc, and the presence of fibrillar cytoplasmic inclusions called Lewy bodies and Lewy
neurites. However, a more global perspective on the PD is developing, motivated by pathological
and clinical findings that extend beyond the basal ganglia. In particular, the majority of PD patients
meet criteria for a secondary diagnosis of mild cognitive impairment that progresses dementia, a
significant contributor to disease morbidity and mortality. The emerging view is that the
abnormalities in α-synuclein (αS) may be responsible for motor and non-motor symptoms in PD
and Dementia with Lewy Bodies (DLB). Significantly, we recently found that abnormal αS can
cause post-synaptic deficits in vitro and in vivo via a microtubule associated protein tau (MAPT)
dependent mechanism. In this proposal, we will directly determine the following hypothesis: 1)
Pathogenic αS species produce cognitive decline tau-dependent post-synaptic mechanisms and
2) MAPT-dependent postsynaptic deficits caused by exogenous αS fibrils/oligomers contribute to
cognitive deficits in sporadic PD and DLB. To determine the mechanistic basis for cognitive
deficits in α-synucleinopathy, we propose following aims: 1) Determine whether tau is required
for αS dependent synaptic and cognitive deficits; 2) Determine if mutant αS-dependent AMPAR
deficits and memory deficits are caused by multiple pathways; 3) Determine whether hippocampal
αS pathology and somatodendritic tau mislocalization correlates with dementia in PD; 4)
Determine if exogenous pathogenic αS induces pre- and/or post-synaptic deficits; and 5)
Determine if pathogenic αS induces defects in synaptic plasticity and memory in a tau dependent
manner.

Public health relevance
While dementia is a significant disability associated with PD and DLB, there are no effective therapies for slowing or reversing progressive cognitive deficit in PD. Proposed studies will provide mechanistic understanding of how α-synuclein abnormalities lead to synaptic deficits and cognitive deficits. Information generated will have direct impact on future efforts aimed at developing therapies for PD.